Einstein's Nathan Shock Center of Excellence in Basic Biology of Aging

The Einstein Nathan Shock Center (E-NSC) has grown to includes internal (46) and external (33) members
who are engaged in meaningful collaborations and programs and are recipients of P&F support. This growth
was accompanied by an impressive publication record E-NSC members as exemplified in 124 papers and
reviews in Nature, Cell and Science journals, a staggering average of approximately five collaborative papers
(with other E-NSC members) per E-NSC investigator and the proactive recruitment and ‘conversion’ of many
members to the E-NSC who were not members for previous submissions. Other resources are also important
for E-NSC success, including large aging programs (P01 and U grants), an ongoing NIH-funded Einstein Aging
(T32) training grant, a complementary graduate course on the Biology of Aging, and resources from funded
projects through the Einstein Glenn Center for Biology of Human Aging. Activities of the E-NSC were
leveraged by supplemental Institutional funding; the Center awarded 26 pilot and feasibility grants, with good
outcomes. The three Research Resource Cores provided services to 167 investigators, offering state-of the art
services with dependable quality control at an affordable price. The (abridged) aims of the E-NSC are: Aim 1)
To enhance and expand ongoing biology of aging research by providing access to cutting-edge technology
and innovative approaches through services that (excluding health span of rodents) do not exist in other NSCs:
a) The Proteostasis of Aging Core (PAC) (Cuervo) will continue to provide assays, reagents and expertise
for the analysis of proteostasis in aging. The PAC Innovation Unit will continue developing and implementing
methodologies for the study of human aging proteostasis. It now includes a drug development consulting
service. b) The Health Span Core (HSC) (Huffman) will continue to provide sophisticated integrative studies
for determination of healthy aging physiology and resources for parabiosis studies. c) The Human Multi-omics
Core (HMOC) (Vijg) will add services for planning and executing single cell epi/genomics analyses to address
important problems in biology of aging. It will provide omic data (whole exome sequencing, aftamer proteomic
data, transcriptomic and metabolomic) from well phenotyped human aging data. Aim 2) To plan and
coordinate geroscience activities, foster collaborations and integrate activities of the Research Cores and
research efforts at Einstein and other institutions. The Administrative Core (Barzilai/Cuervo) will continue
implementing and promoting enrichment activities through seminars, mini-retreats and NSC national meetings,
and developing resources to facilitate integration of groups engaged in aging research at institutions with
limited aging research support; the Core also ensure that E-NSC services are well publicized. Aim 3) To
provide support and an environment conducive to promotion of thriving new investigators in biology of
aging through a Research Development Core (Milman/Singh). We will provide P&F awards and mentoring to
new aging researchers and support for expansion/divergence of other ongoing exciting research programs.

Public health relevance
The Einstein-Nathan Shock Center of Excellence is part of the biggest Institute in the world for the study of the biology of aging , encompassing approximately 80 labs, which have emerged to stimulate the investigator intellectual environment for specific fields of research and to provide technology that is not practicable for the individual scientist. With support for three research resource cores, pilot & feasibility awards, a designated mentor system, program enrichment and a yearly mini-retreat, this Einstein-Nathan Shock Center will continue to transform the field with the goal to delay human aging and its associated diseases.